Investigating the mechanisms driving host-associated microbial community dynamics

PROJECT SUMMARY/ABSTRACT
The gut microbiome is a complex ecosystem of microorganisms that live in the gastrointestinal tract. The gut
microbiome and alterations to the gut microbiome, or dysbiosis, are linked to a number of human diseases.
Variation in the gut microbiome plays a key role in microbiome-associated disease, but the rules governing
microbial community dynamics are still being discovered. The composition and function of gut microbial
communities change in response to variation in the host’s internal and external environment. While changes in
response to antibiotics, disease, and diet are profound, gut microbiome changes associated with normal
variation in host physiology or differences in host genetics are more subtle. Research in my lab focuses on
understanding drivers of gut microbial community dynamics, particularly those related to changes in the
environment or variation host physiology. Both environmental and host influences on the gut microbiome have
been studied, but the relative contributions of each are still unclear and the mechanisms underlying these
interactions have not been fully explored. My research program will focus on three main themes over the next
five years: 1) examining how environmental and host factors interact to shape microbial community
development and variation across an individual’s lifespan; 2) developing a more complete understanding of
how normal variation in host physiology influences the gut microbiome; and 3) revealing the mechanisms by
which host physiology contributes to variation in the gut microbiome. My lab uses metagenomics coupled with
behavioral observations and non-invasive and minimally invasive methods to track hormones and immune
activity to detect associations between environmental change, host physiological variation, and the gut
microbiome in both wild animal systems and humans. Additionally, we pair this approach with cutting-edge
computational tools and in vitro fermentation methods to determine the directionality and causality of
relationships between the gut microbiome and host factors. This approach will allow us to understand the
fundamental rules governing host-associate microbial community assembly and dynamics. This project will
significantly contribute to our understanding of the range of normal variation in host-microbe interactions. The
results of this project are key to predicting drivers of gut microbial dysbiosis and designing effect microbiome-
targeted interventions and treatments.

Public health relevance
PROJECT NARRATIVE Changes in the gut microbiome are associated with multiple diseases, but we lack a full understanding of the biological processes and mechanisms that drive gut microbiome variation. This proposal will provide basic scientific knowledge about 1) the relative contributions of host and environmental factors to gut microbiome variation; 2) the impact of normal variation in host physiology on the gut microbiome; and 3) the directionality of interactions between host endocrine function, host immune function, and the gut microbiome. The results of this project will provide essential information for developing effective microbiome-based treatments.